Behavioral Pharmacology of Opioid/Xylazine Mixtures

PROJECT SUMMARY
The opioid crisis continues despite the availability of several FDA approved medications for treating opioid
abuse and overdose. This public health crisis has worsened significantly over the past several years with the
COVID-19 pandemic and the increased availability of fentanyl and related ultra-potent analogs. Recently, there
has been a marked rise in overdose deaths involving opioids and xylazine, a non-opioid with sedative,
analgesic, and muscle relaxant properties and authorized only for veterinary use. It remains unclear why use of
opioid/xylazine mixtures has increased so rapidly. Use of xylazine might be intentional in some situations but
not others as it is commonly found as an adulterant in other drugs. Having agonist properties at alpha-2
adrenergic receptors, xylazine decreases release of norepinephrine and dopamine, and causes drowsiness,
hypotension, bradycardia, hypothermia, respiratory depression, and coma as well as soft tissue damage that
can lead to necrotic skin lesions. Xylazine shares many effects with opioids, increasing the risk of adverse
effects, including fatal overdose, when combined with an opioid. Anecdotal reports suggest that xylazine
enhances the reinforcing and subjective effects of opioids and diminishes the severity of opioid withdrawal
which might contribute to increased use; however, these hypotheses have not been tested experimentally. In
the case of overdose, treatment with naloxone (Narcan®) blocks only the effects of the opioid, thus additional
measures are required to successfully treat opioid/xylazine overdose. Repeated exposure to xylazine might also
lead to physical dependence and withdrawal, and it remains unclear whether xylazine alters opioid withdrawal.
Though medications are approved for reversing effects of xylazine in veterinary care, there are currently no
approved medications for treating xylazine overdose or withdrawal in humans. Proposed studies use well-
established methods and a highly translational species to improve our understanding of interactions between
opioids and xylazine as well as to elucidate factors contributing to the use of opioid/xylazine mixtures, which
will help to drive the discovery of safe and effective treatments.

Public health relevance
PROJECT NARRATIVE Recent increased rates of overdose deaths involving opioids and xylazine are quickly becoming a major public health problem, exacerbating the opioid crisis which was already worsening in the wake of the COVID-19 pandemic and increased availability of fentanyl. There are little/no data on why opioid/xylazine mixtures are used, the nature of interactions between opioids and xylazine, or potential treatments. Proposed studies use well-established methods and a highly translational species to improve our understanding of interactions between opioids and xylazine as well as to elucidate factors contributing to the use of opioid/xylazine mixtures, which will help to drive the discovery of safe and effective treatments.